IGF::OT::IGF TASK ORDER #001 - PERFORMANCE AREA A - ADMINISTRATIVE AND OVERALL CLINICAL OPERATIONS SUPPORT

Administrative support for PHASE I CLINICAL TRIALS FOR DEVELOPMENT OF NEUROTHERAPEUTICS

Public health relevance
Phase I clinical trials for neurotherapeutics